Nanomedicine-Driven Strategies to Repair Peripheral Nerve Injuries

PROJECT ABSTRACT
Appropriate functioning of the nervous system is tremendously important to our quality of life. The nerves
within our body branch from the spinal column and can extend up to one meter away. Peripheral nerve injuries
are a common occurrence and can readily heal in most cases. However, end-organs beyond ~18 inches away
from the nerve body, are highly susceptible to poor reinnervation outcomes and long-term detriments. A main
reason for this being the slow growth rate of the axons (1-2mm/day or 1 inch/month). Some tissues, such as
skeletal muscle, can remain ready for reinnervation for 18-24 months. However, current intervention strategies
are limited, and most injuries are left to resolve naturally. This application aims to develop a strategy capable of
promoting quicker neurite outgrowth and preserving the muscle in a healthy state until reinnervation can occur.
This application focuses on tissue-nanotransfection mediated delivery of non-viral gene cargo to induce
molecular changes and to reprogram cells. The ability to deliver cargos locally to the site of injury opens
avenues beyond nerve injury for gene and cell-based therapeutics with a precision medicine approach.
Completion of the F99 phase sets a strong intellectual, technical and professional foundation for the
postdoctoral (K00) phase of this award. During the K00 phase, training in understanding how cell and gene-
based therapies impact neurodevelopmental and neurodegenerative conditions will develop knowledge,
expertise, and skills essential to becoming an independent investigator.

Public health relevance
Project Narrative: The thesis and F99 phase of this proposal investigates a nanomedicine-based approach to drive the peripheral nerve regeneration and functional recovery, while also working to limit neuromuscular degeneration resulting from the loss of nerve function by creating new neurons within the muscle to promote and preserve healthier state. The applications of genetic and cell-based therapies extend well beyond the study of nerve regeneration and will be applied to neurodevelopmental disorders in the K00 period. Completion of the F99 phase will provide professional, intellectual, and technical training in preparation for the transition to the postdoctoral phase (K00) of the award.